Skeletal muscle protein structural dynamics and function drive applications to drug discovery

Our goal is to develop small-molecule drugs for treatment of skeletal muscle disorders related to
dysregulation of intracellular calcium, focusing on specific proteins in the sarcoplasmic reticulum (SR).
Each Aim starts with the design of fluorescent biosensors (specific SR proteins labeled with fluorescent donor
and acceptor), to be used in high-throughput screening (HTS) of small molecules. A key innovation is our recently
developed HTS approach based on fluorescence lifetime (FLT) detection of protein structural changes by
fluorescence resonance energy transfer (FRET). Our combination of FRET biosensor engineering with
unique FLT detection has produced an unprecedented combination of sensitivity, specificity, speed, and
precision in protein structure-based studies of mechanism for drug discovery. We previously validated this
approach through applications to cardiac muscle. We now focus on skeletal muscle, targeting the two key SR
proteins involved in Ca regulation, the Ca release channel (RyR1) and the calcium pump (SERCA1a).
Aim 1: Targeting RyR1 leak reduction. Our biosensor is based on FRET between two regulatory proteins
(FKBP12.0 and CaM) bound to RyR1. In pilot screens, we have shown that this FLT-based FRET assay can
detect small molecules that restore aberrant RyR1 function, in which the Ca channel leaks Ca from the SR into
the cytoplasm, inducing myopathies. We will carry out larger-scale screening, to identify new drug candidates,
then use cellular and in vivo muscle assays to test the reversal of undesirable calcium leak in fibers and mice.
Aim2: Targeting SERCA1a activation. We seek a complementary solution to combat Ca leak – enhancing
SERCA1a activity to pump Ca back into the SR lumen. This approach also targets factors (e.g., mutation or
oxidation) that impair SERCA1a activity. We will use two complementary approaches, building on our previous
studies with SERCA2a (cardiac), with fluorescent biosensors expressed in live cells. (A) We will use an
intramolecular FRET biosensor (donor and acceptor attached to different domains of SERCA1a), to screen a
small-molecule library to detect compounds that bind to SERCA, alter enzyme structure, and activate Ca
transport. (B) We will use an intermolecular biosensor, with donor on SERCA1a and acceptor on the SERCA1a
regulator sarcolipin (SLN), to detect compounds that activate the enzyme by uncoupling the inhibitory effects of
SLN. We will evaluate potency and efficacy of drug candidates, using assays on myofibers and muscles, both in
vitro and in vivo in mouse models including pre-clinical longitudinal drug testing.
We have assembled a multi-PI team with complementary expertise and decades of successful collaboration,
led by David Thomas (SERCA1a, FLT-FRET), Razvan Cornea (RyR1, biosensor engineering), and Dawn Lowe
(skeletal muscle functional analysis). We will also be joined by collaborators with complementary expertise in
medicinal chemistry (Aldrich) and myofiber Ca assays (Launikonis), and two consultants with unique expertise
on animal models of disorders in muscle Ca regulation (Dirksen and Hamilton).

Public health relevance
Project Narrative This is a collaborative project bringing together several leading muscle research labs with complementary expertise in structural biophysics, physiology, animal models, and medicinal chemistry. Our goal is to develop and apply technology for drug discovery, targeting calcium transport regulation in skeletal muscle, with direct relevance to skeletal myopathies, as well as numerous other disorders for which improved therapies are urgently needed.